Interaction of estrogen, age, and activity on musculoskeletal strength in females

Strength loss occurs with age affecting quality of life and impinges upon healthspan. 17β-estradiol (E2)
deficiency in females also causes strength loss. The overall goal of this project is to determine the cellular and
molecular mechanisms through which E2 deficiency perturbs skeletal muscle and contractile functions with
age. The sole focus of our research has been on aging females and in this competitive renewal submission,
we also seek to determine mechanisms of E2 in male muscle as the impact of estrogens in male non-
reproductive physiology is becoming increasingly recognized. Results from the previous funding periods have
led to novel hypotheses outlined in this proposal. Specifically, Aim 1 tests the hypothesis that E2 signals
through estrogen receptor α (ERα) and the G protein-coupled ER (GPER) in skeletal muscle to enhance
dynamic strength in male as well as female mice. We use genetic, surgical, and pharmacologic approaches to
probe both the ligand and receptor sides of E2-ER signaling. We pair this approach with comprehensive in
vivo and in vitro measures of muscle contractile functions to elucidate mechanisms and determine the long-
term consequence of E2-ER disruption in muscle. While the particular muscle proteins to be analyzed in the
first aim are guided by specific contractile outcomes that are affected by E2-ER signaling, Aim 2 takes an
unbiased approach to quantitate phosphoproteins that are critical for strength yet altered in aged and E2-
deficient muscle. This will be accomplished through the development of a novel parallel reaction monitoring
(PRM) assay with computational modeling, which is based on our global phosphoproteomic work that
identified differentially expressed phospho-peptides related to calcium signaling and contractile proteins in
several E2-replete vs E2-deficient muscle conditions. Our customized PRM assay will further predict
candidate E2-sensitive kinases that will be validated in high-throughput assays to yield potential
gerotherapeutic targets for preserving muscle strength with age. It has been shown that 17alpha-E2, the minor
and weak epimer of E2, extends lifespan and improves several characteristics of healthspan in male mice.
Aim 3 is designed to test the hypothesis that skeletal muscle will be enhanced by 17alpha-E2 in both aged
males and females through activation of ERα and downstream signaling. This aim brings forth the intriguing
prospect that 17alpha-E2 is a non-feminizing geroprotector that extends healthspan by supporting muscle
strength and thus physical activity, movement, and quality of life. Accomplishing these three aims will solidify
that change in sex hormones and their receptors is one of the pleiotropic mechanisms underlying muscle
weakness with age and addresses the long-term goal of our research program, which is to determine
estrogenic mechanisms that preserve strength with aging, regardless of sex.

Public health relevance
PROJECT NARRATIVE Loss of muscle strength occurs with age and in females estradiol deficiency contributes to strength loss. Through the uses of genetic, surgical, and pharmacological interventions to alter both estradiol levels and estrogen receptors, our project aims to not only expand our understanding of estrogenic mechanisms affecting skeletal muscle function in females but also determine if there is a role in preservation of muscle strength in males. Such understanding paves the way for estrogenic treatments that will impact the field of aging in both women’s and men’s health from multiple perspectives, beyond reproductive considerations